Unified high performance analysis of imaging biomarkers for Alzheimer's disease

DESCRIPTION (provided by applicant): Alzheimer's disease is a neurodegenerative disease of the brain causing impairments to memory and cognitive functions, eventually leading to death. The causes of Alzheimer's disease and mechanisms of disease progression are not fully understood, but an enormous amount of effort is being focused on the issues in research and pharmacologic interventions. Brain Image Analysis, LLC has developed NeuroAnalytica to provide high quality brain morphometry measures for biomarkers in Alzheimer's disease. This Phase II project will expand the basic measures to include a wide range of modalities and measures that research has shown to be useful in as potential biomarkers in Alzheimer's disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease is a neurodegenerative disease of the brain causing impairments to memory and cognitive functions, eventually leading to death. The causes of Alzheimer's disease and mechanisms of disease progression are not fully understood, but an enormous amount of effort is being focused on the issues in research and pharmacologic interventions. Brain Image Analysis, LLC has developed NeuroAnalytica to provide high quality brain morphometry measures for biomarkers in Alzheimer's disease. This Phase II project will expand the basic measures to include a wide range of modalities and measures that research has shown to be useful in as potential biomarkers in Alzheimer's disease.